Canagliflozin as a Neuroprotective Agent to Improve Neuroinflammation and Cognitive Function during Aging

ABSTRACT
Aging is the dominant risk factor for most chronic diseases including neurodegenerative diseases.
There is now ample evidence, in mice, that the process of aging can be delayed by
pharmacological compounds that target numerous cellular and molecular pathways that have been
implicated in the aging process and also delay multiple forms of late-life illness, including
Alzheimer's disease (AD). In collaboration with the Intervention Testing Program (ITP), we have
recently demonstrated that an FDA-approved anti-diabetes drug, Canagliflozin (Cana), a sodium-
glucose transporter 2 (SGLT2) inhibitor, extended the lifespan in the genetically diverse UM-HET3
male mice by 14%, without an effect on females. The question of whether Cana has beneficial
effects on the aging brain or amelioration of age-associated diseases in the brain remains open.
Our new study demonstrated that Cana exhibits neuroprotective properties, such as improved
central insulin responsiveness and reduced region-specific neuroinflammation. Furthermore, Cana
treatment improved locomotor activity and exploratory behavior in aged male mice. Our preliminary
data further reveal significant changes in hypothalamic transcriptome associated with decreased
expression of genes related to activation of inflammatory responses specifically genes related to
NLRP3 inflammasome activation in aged Cana-treated mice. Our central hypothesis is that Cana
exhibits neuroprotective properties that may be applicable for the treatment of the aging brain
and/or neurodegenerative diseases. This hypothesis will be assessed using genetically diverse
UM-HET3 mice fed with Cana from 7 months of age and followed longitudinally by combining
physiological, molecular, and genetic approaches. We will determine the effects of Cana treatment
on cognitive function during aging and correlate this with the measurements of Cana levels in the
brain. We will assess the Cana effect on microglia inflammasome activation and study brain spatial
transcriptomic changes in aged mice to identify key pathways/genes mediating the
pharmacological effects of Cana. Finally, we will determine the effects of Cana on cognitive
performance using two well-established mice models of AD, 5xFAD and PS19 Tau. Our study has
the potential to test the pharmacological effects of an established drug on cognitive degeneration
in aging, as well as to identify novel cellular and molecular mechanisms underlying this
pharmacological effect. Taken together, our study will validate Cana as a drug that can be rapidly
used for preventing or treating AD in humans.

Public health relevance
NARRATIVE The experiments proposed in this application will directly test the effects of a novel anti-diabetes drug, Canagliflozin on cognitive function, molecular signaling pathways that modulate aging, and cells sex-specific heterogeneity immune and transcriptional profile in aged mice and the Alzheimer's disease mice models. These studies are expected to have a substantial translational impact since Cana is already in clinical use. Thus, identifying Cana as a potential treatment for age-related neurodegenerative diseases can improve health outcomes and quality of life for a large group of society.